2D IR spectroscopy of voltage gating in potassium ion channels

Abstract
Voltage-gated potassium ion channels (Kv) are responsible for reestablishing the resting potential of cells upon
membrane depolarization. They consist of two domains, a voltage sensing domain (VSD) and a pore domain.
The voltage-dependence of the VSD is sensed by the positively charged TM4 helix, causing a translation and/or
secondary structure change that tugs on the pore domain to open the channel. There exist many high-resolution
atomic structures of Kv channels in the depolarized state, but since it is experimentally difficult to obtain structural
information under an electric field, most of the information about the polarized state comes from mutated proteins
that approximate the hyperpolarized structure and from molecular dynamics simulations. During the last round
of funding, we developed a method for measuring two-dimensional infrared (2D IR) spectra of membrane-
embedded proteins under an electric field. We did so by using surface enhanced plasmons to increase the
sensitivity of 2D IR spectroscopy by many orders of magnitude, making possible measurements on a single
bilayer of membrane-embedded proteins across which a potential can be applied. Working with the Valiyaveetil
lab, we have now measured voltage-dependent structural changes in the VSD of KvAP using cyano-labeled
amino acids incorporated into the TM4 helix with in vivo nonsense suppression. In collaboration with the
Kananenka group, we simulated the local electric field on the cyano group from molecular dynamics simulations,
thereby relating the structural features of the hyperpolarized VSD to the experimental measurements. We also
developed a sample cell that can create a fast voltage jump, enabling successive 2D IR spectra to measure the
structural kinetics of the proteins as they switch from the depolarized to hyperpolarized state (or vice versa). In
Aims 1 and 2 of this proposal, we will apply this methodology to study the voltage-dependent structural changes
of the VSD from KvAP and Shaker, respectively, as well as in the full ion channels. In Aim 3, we will further
develop and apply voltage-triggered 2D IR spectroscopy to time-resolve their structural motions. This
combination of 2D IR spectroscopy, cyano tags or isotope labeling, and molecular dynamics simulations is a
new means of investigating the structural dynamics of the hyperpolarized states of potassium ion channels and
other membrane proteins.

Public health relevance
Project Narrative: Voltage-gated ion channels are responsible for controlled, rapid permeation of ions across the cell membrane. They are triggered by the voltage sensing domain. The aim of this proposal is a better fundamental understanding of the mechanism of structure changes that regulate transport. 1